UPPER AND LOWER ANTHROPOMETRY TO ASSESS THE PROGRESSION OF WEAKNESS IN ALS

To compare the anthropometric determination of muscle mass in the upper (arm muscle area) and lower extremities with isometric muscle power in ALS patients participating in a clinical trial of BDNF (Brain Derived Neurotrophic Factor).